Environmental Chemical Impact on the Host-Microbiome Interaction

PROJECT SUMMARY/ABSTRACT
There is an increasing level of appreciation in the fields of environmental health sciences and toxicology on the
critical role of the gut microbiota on the host response to toxic chemical exposure. The microbiota is known to
directly and indirectly influence the extent of toxicity of dietary and environmental chemicals, and has been
implicated in a wide-range of diseases including metabolic disorders, cancer, and inflammatory diseases. Careful
and rigorous experimentation to determine the mechanism by which the microbiota influences environmental
chemical exposure will lead to a more complete understanding of how these chemicals disrupt the host-
microbiota interaction and will generate novel insights into the key signaling pathways underlying those
perturbations and adverse health outcomes. Importantly, studies of the microbiota and environmental chemicals
may provide key insights that will better inform risk assessment that could positively impact human health. In this
R35 RIVER proposal, we plan to work across three innovative and complementary themes to address the
unifying hypothesis that environmental chemical exposure perturbs the host-gut microbiota interaction to
adversely affect health. First, using mouse models, we will explore the idea that early-life exposure to
environmental chemicals impacts later life health outcomes (e.g., metabolic disorders, acute and chronic
inflammatory bowel disorders) via alterations in the host-gut microbiota axis. Second, we will examine how
environmental chemicals impact common commensal microbes of the gastrointestinal tract including their
metabolic activities and potential to modulate host physiology. Third, we will explore new pathways involved in
microbiota control and influence of host physiologic processes. To achieve these goals, we have assembled a
diverse, collaborative, and highly interdisciplinary team consisting of experts in biochemistry, enzymology,
immunology, metabolism, microbiology, transcriptional regulation, and toxicology. The Patterson lab has a long
history of making unique and seminal discoveries along the host-gut microbiota axis and thus is well-positioned
with cutting-edge technology and approaches, experience, innovative ideas, and an open/collaborative
environment to advance our understanding of the host-gut microbiota interaction and help to move the field
forward. From a translational standpoint, these studies may lead to new protective approaches toward dietary
and environmental toxicity through design of new pre/probiotics.

Public health relevance
NARRATIVE The gut microbiota can be perturbed by environmental factors including diet composition, xenobiotic exposure (e.g., environmental toxicants, antibiotics) and life-style (smoking, exercise, stress, social interactions); thus, a better understanding of the functional role of microbiome and its regulation of host metabolic responses is an important prerequisite for designing microbiome-specific therapeutic strategies. This study will provide insight into how exposure (including dose and timing) to environmentally relevant toxicants interacts with the host and gut microbiota to affect health. Important outcomes include improved understanding of the gut microbiota in the response to toxic insult and the identification of toxicity levels that can be used to establish possible microbial toxicity endpoints which will likely help to inform hazard identification and risk assessment.